Shared Resource - Biostatistics & Bioinformatics Shared Resource

ABSTRACT
The goal of the Biostatistics & Bioinformatics Shared Resource (BBSR) is to provide basic, translational, clinical
and population science investigators at the Georgetown Lombardi Comprehensive Cancer Center (LCCC) with
access to high-quality statistical science and informatics. Ming Tan, PhD, Chair of the Department of
Biostatistics, Bioinformatics and Biomathematics (DBBB), and Subha Madhavan, PhD, Founding Director of the
Georgetown Innovation Center for Biomedical Informatics (ICBI), are codirectors of the BBSR. The BBSR
provides statistical and bioinformatics support for designing studies, managing and analyzing data. Its functions
include study design; statistical analysis and reporting of research studies, including clinical trials, studies with
high-dimensional omics and imaging data (including pathway analysis and computational modeling) and
providing access to deidentified electronic health records (EHRs); review and monitoring of clinical protocols
through membership on the Protocol Review and Monitoring Committee (PRMC) and the Data and Safety
Monitoring Committee (DSMC); and provision of biostatistics and informatics training and expertise in collecting,
integrating, managing and applying biomedical data to innovative, transdisciplinary cancer research projects. In
addition, the BBSR provides LCCC investigators with advanced statistical and bioinformatics methods and
expertise developed independently by BBSR faculty. The BBSR has excellent computing resources, informatics
infrastructure and software necessary for efficient and effective support of LCCC research through its
engagement with ICBI and the Georgetown University (Georgetown) Information Services (UIS). Through these
collaborations, the BBSR focuses on Web and cloud based development for biomedical applications. It has
collaborated with members in all four LCCC research programs (Breast Cancer [BC], Cancer Prevention and
Control [CPC], Experimental Therapeutics [ET], and Molecular Oncology [MO]) and with multiple Shared
Resources, including the Genomics & Epigenomics Shared Resource (GESR), the Survey, Recruitment &
Biospecimen Collection Shared Resource (SRBSR), and the Proteomics & Metabolomics Shared Resource
(PMSR) as well as the Clinical Research Management Office (CRMO). The BBSR supports the development
and maintenance of standardized and scalable information architecture to connect data and metadata from
clinical, biospecimen and research systems to enable all forms of cancer research. BBSR faculty members were
coauthors on 156 LCCC member publications in the current funding period. During 2017, BBSR members
supported 42 research projects from 25 LCCC investigators.